A novel role of fascin in cancer metastasis

Our long-term goals are to define the molecular mechanisms by which fascin controls cancer metastasis and
progression. Cancer metastasis involves the dissemination of cancer cells from primary tumor to distant organ,
and the expansion of disseminated metastatic cells to form secondary tumor. It has been well established that
the actin cytoskeleton is frequently dysregulated to promote cancer cell motility, invasiveness during metastatic
dissemination. However, the post-dissemination role of the actin cytoskeleton in cancer metastasis is largely
unexplored. Fascin is the most frequently overexpressed actin binding protein in metastatic cancer, and its
overexpression is uniformly associated with metastatic disease, aggressive clinical course and shorter survival
across different cancer types. It is generally thought that fascin drives cancer metastasis by strengthening the
actin cytoskeleton and promoting cell motility. In preliminary studies conducted in NSCLC models, we
discovered a novel role for fascin in promoting metastatic colonization and expansion and augmenting cancer
cell stemness by remodeling mitochondrial actin filaments. We propose that fascin enhances the self-renewal
of cancer stem-like cell and metastatic expansion through a novel fascin-mitochondria-AMPK-YAP/TAZ
pathway. We will build on these exciting preliminary findings to investigate the functional role of fascin-
mediated remodeling of mitochondrial actin filaments in Aim 1. We will then define the role of the AMPK-
YAP/TAZ pathway in fascin-mediated augmentation of cancer cell stemness in Aim 2. In Aim 3 we will
determine the novel mitochondrial role of fascin and mitochondrial actin filaments in fascin-mediated NSCLC
metastasis, and will explore the feasibility to inhibit cancer cell stemness and metastatic recurrence by
targeting fascin. The success of proposed studies will cause a paradigm-shift in our understanding of the
dysregulated actin cytoskeleton in metastatic progression, and will potentially provide novel avenues to prevent
NSCLC metastatic recurrence.

Public health relevance
This project investigates the basic mechanisms underlying the regulation of mitochondria and metabolic reprograming during metastasis, which accounts for more than 90% of cancer-related death. The anticipated results from this proposal will significantly advance our understanding of cancer metastasis, and potentially provide novel strategy for preventing metastatic progression.